Studies in Global Mortality

DESCRIPTION (provided by applicant): Mortality patterns reflect fundamental characteristics of societies and help to reveal important changes in population health over time. In order to improve our understanding of such topics, we propose here to examine historical and contemporary mortality patterns for a wide range of countries, including the United States. The work for this project is organized into three parts. The first part consists of an analysis of comparative mortality trends in high-income countries. In the second part, we will continue our efforts to develop publicly accessible data resources for the analysis of global mortality trends, including the developing world. In the third part of this project, we will develop new and better methods for estimating and analyzing mortality in both developed and developing countries. The substantive questions that motivate this project are focused on certain features of recent mortality trends. Specifically, we will examine the pronounced slowdown in the pace of mortality reduction at advanced ages in the United States since around 1980. This trend has affected female mortality in particular, contributing to an overall narrowing of sex differences. We propose to investigate the contribution of key risk factors (especially, smoking and obesity) to these recent trends. To enrich these studies, the project includes a detailed plan for collecting and organizing historical mortality data by cause of death, which will be shared publicly via the Human Mortality Database (www.mortality.org). The project will also address a number of important issues regarding methods for estimating current and historical mortality levels, especially in developing countries. We will develop updated methods of indirect estimation using a new system of model life tables that we have proposed recently. We will also develop new and better methods for quantifying the uncertainty of mortality estimates, especially for countries that lack complete and reliable data from censuses and vital registration. To facilitate this research, we are building a complex database for storing all forms of data that are typically used for estimating both all-cause and cause-specific mortality in national populations.

Public health relevance
PUBLIC HEALTH RELEVANCE: "Studies in Global Mortality" examines historical and contemporary mortality patterns for a wide range of countries, including the United States. Estimating mortality and its causes is an important step in determining the relative importance of factors preventing longer life, and as such are directly relevant to the goals of the National Institute on Aging. Project Narrative "Studies in Global Mortality" examines historical and contemporary mortality patterns for a wide range of countries, including the United States. Estimating mortality and its causes is an important step in determining the relative importance of factors preventing longer life, and as such are directly relevant to the goals of the National Institute on Aging. __SpecificAimsTextDelimiter__ 2. Specific Aims This is a renewal application for an existing award from the National Institute on Aging (R01 AG11552). Since 2004, this award has supported research on several interrelated topics, including: comparative mortality trends and differentials by age, sex, social class, and cause of death; methods of mortality estimation for national populations; theoretical concepts and measures of mortality or longevity; and innovative approaches to classic analytical problems such as trend decomposition and mortality forecasting. The award has supported the continuing development of the Human Mortality Database (HMD), a unique and publicly accessible collection of mortality and population data primarily for developed countries, as well as exploratory work on a new and complementary database designed to accommodate mortality data from countries with less reliable and more varied data systems and to serve eventually at the primary database management tool for all aspects of this research project. In the next phase, we are proposing an integrated program of work that is a natural extension of our research during the past five years. A change of title (from "Longevity and Mortality in Industrialized Countries" to "Studies in Global Mortality") reflects the broader geographic scope of our current and future research program. Both the proposed project and this application are organized around two interrelated areas of work and investigation: 2.1 Databases for the analysis of total and cause-specific mortality a. Human Mortality Database (HMD). In addition to regular updating, we will expand and improve the Human Mortality Database, mainly by: (1) adding or extending data series for a small number of countries; (2) providing more systematic information about data quality for all countries; and (3) adding data series on cause of death using a list of 75-100 categories chosen to minimize disruptions due to revisions of the international classification system (without adjusting the underlying data). b. Database for Mortality Estimation and Monitoring (DMEM). We will build a database management system to serve as a comprehensive repository of mortality data in various formats, including the diverse forms of raw data needed for estimating age-specific mortality rates for all countries of the world; the DMEM will be used for adding detailed information by cause of death to the HMD and will eventually become the primary data management tool for all aspects of this research project. c. Evaluation of data quality. We will develop a comprehensive set of quantitative indicators to provide a concise comparison of data quality across countries and over time for all data inputs and outputs in the Human Mortality Database; we will also investigate and document the relationship between the quality of raw data and the accuracy of various derived indicators of mortality or longevity. d. Descriptive studies. We will perform descriptive analyses of mortality trends and differentials by age, sex, and cause of death for high-income countries using standard techniques; breakdowns by cause of death will use new data series developed as part of this project. 2.2 Methods of mortality estimation for national populations a. Indirect methods of mortality estimation. We will review and evaluate existing methods of estimating mortality in developing countries and, where appropriate, develop new techniques; we will also investigate methods for quantifying the uncertainty of such estimates. b. Case studies of mortality estimation. We will study problems of mortality estimation in the developing world by focusing on several Latin American and Asian countries (or sub-national regions); for these populations we will estimate current and historical mortality levels using both direct and indirect methods, taking into account all available data sources and adjusting raw data as necessary. c. Methods for reconstructing data series by cause of death. We will investigate methods for adjusting cause-of-death mortality data to create historical series that are comparable over time, by correcting distortions due to changes in the international classification system and other coding practices.